Vitamin B Metabolism in Host-Parasite Interactions

PROJECT SUMMARY/ABSTRACT
Parasitic nematodes infect approximately 1.5 billion people worldwide, making them the most
prevalent infectious agents globally. Current strategies to control nematode infections primarily
include the use of anthelmintic drugs and community health education. However, significant
challenges such as drug resistance and reinfection persist. Vitamin B, a complex of essential
water-soluble vitamins crucial for cellular metabolism, is not synthesized by animals but must be
acquired through their diet. Nonetheless, our recent research has shown that many parasitic
nematodes have evolved partial or complete pathways for producing these vitamins. This project
aims to clarify the role of vitamin B metabolism in the host-parasite interaction by characterizing
their metabolic pathways in both hosts and parasites. We aim to identify which vitamin B
components nematodes obtain directly from their hosts and which they synthesize themselves,
and how this balance affects their growth and reproduction. Given that vitamin B pathways are
typically absent in animals, understanding these pathways could lead to the development of novel
control strategies, such as drugs that target specific enzymes within these pathways. Additionally,
this project will develop functional genomic tools for parasitic nematodes, providing optimized
heritable genome editing tools. Through this research, we aim to train scientists and achieve
breakthroughs that deepen our understanding of the energy and nutritional needs of parasitic
nematodes.

Public health relevance
PROJECT NARRATIVE Parasitic nematodes establish long-term relationships with their hosts, from whom they obtain essential nutrients to survive. This project focuses on understanding how nematodes acquire their supply of Vitamin B, a group of essential nutrients vital for cell metabolism. Additionally, the project will develop genomic tools that facilitate the study of these parasites, enhancing our ability to explore and potentially disrupt their lifecycle.